3D genome-based transcriptional program for male germline differentiation

Project Summary
Spermatogenesis produces fertilization-competent sperm that ensure the continuity of life. The 3D
chromatin structure in male germ cells changes dynamically during spermatogenesis. However, the
relationship between the 3D genome and transcription in the male germline remains largely unknown. To
elucidate how the 3D genome regulates the transcriptional program during mouse spermatogenesis, I
performed high-resolution Hi-C in the male germline. I found that CTCF-mediated 3D genome formation in
undifferentiated spermatogonia serves as an epigenetic memory, initially establishing a gene expression
program that is subsequently used to direct gene expression during late spermatogenesis. My central
hypothesis is that the 3D genome predetermines a transcriptional program that directs subsequent
spermatogenic differentiation. Elucidating the molecular mechanism by which this 3D genome is formed will
provide insight into how the transcriptional program is established to ensure unidirectional spermatogenic
differentiation. Aim 1 will determine whether the 3D genome is established in prospermatogonia by capturing
Hi-C and CTCF profiles from PGCs to undifferentiated spermatogonia. Aim 2 will elucidate molecular
mechanisms underlying formation of the 3D genome by determining how specific CTCF-binding sites are
selected from PGCs to undifferentiated spermatogonia. Completion of these aims will elucidate how the
transcriptional program for male germline differentiation is established from the perspective of the 3D genome
during the period from PGCs after sex determination to conversion to spermatogonia, thereby providing
mechanistic insight into how male germ cell identity is established. This research will contribute to the
treatment of male infertility and the improvement of human reproductive success in the future.
So far in my postdoctoral career in the Namekawa lab at UC Davis I have received training in
experimental and analytical skills for comprehensive epigenomic studies, which is the basis for this research
proposal. In the K99 phase, I will receive training in analysis techniques specific to 3D genomes and develop
and refine my future directions. With the training plan and support of the K99/R00 award, this project will
provide me with a strong foundation for success as an independent investigator pursuing important biological
questions in germ cells.

Public health relevance
Project Narrative The gene expression program in male germ cells ensures unidirectional spermatogenic differentiation. This study will identify regulatory mechanisms by which the 3D genome in fetal male germ cells programs gene expression required for subsequent differentiation after birth. Completion of this proposal will elucidate how the transcriptional program of male germ cell differentiation is established and will contribute to the treatment of male infertility and the improvement of human reproductive success in the future.